RNA's Role in Double-Strand Break Repair

PROJECT SUMMARY/ABSTRACT
Double-strand breaks (DSBs) are a highly toxic form of DNA damage. The accurate and preferred DSB repair
pathway is homologous recombination (HR), which uses the sister chromatid as a repair template during S/G2
cell cycle stages. Alternatively, the error-prone nonhomologous end joining (NHEJ) ligates broken ends together
primarily during G1. Recently, data in yeast suggest that RNA can be used as a template for DNA DSB repair
through reverse transcriptase (RT) activity. While human cells have shown that RNA transcription promotes the
recruitment of DNA repair proteins to DSBs, there is no evidence that RNA is directly templating repair. This has
so far been difficult to study due to a lack of assays to measure this scarless repair pathway. Therefore, we
developed a fluorescence-based BFP-to-GFP conversion reporter that measures repair of a DSB in the BFP
gene via a single-stranded donor oligonucleotide coding for GFP. From this reporter, ribonucleotides within a
DNA donor could template DSB repair in human cells, necessitating the use of a reverse transcriptase for this
RNA-templated DSB repair (RT-DSBR). Through a CRISPR-Cas9 screen, we identified the involvement of
Polymerase Zeta (PolZ). We validated the role of PolZ in RT-DSBR through the BFP-to-GFP assay as well as a
sequencing-based assay using a pure RNA donor with an insertion signature. Therefore, the objective of my
project is to unveil how PolZ and RNA work together to drive RT-DSBR in human cells. I hypothesize that mRNA
can template DSB repair at highly transcribed regions and that PolZ is the reverse transcriptase that mediates
this activity. The first part of my research will investigate the mechanistic basis of PolZ as an RT during RT-
DSBR (Aim 1). I will identify the subunits of PolZ necessary for RT-DSBR activity via a pure RNA donor assay
and use structure-function analysis to confirm its reverse transcriptase catalytic domain (Aim 1.1). I will next use
immunofluorescence to visualize if PolZ recruitment to breaks is dependent on its scaffolding subunit REV1 and
on the presence of RNA (Aim 1.2). The second part of my research will elucidate RT-DSBR activity via an mRNA
donor transcribed at the site of the break (Aim 2). I will detect if RT-DSBR occurs endogenously at highly
transcribed genes by using intron loss as a proxy for the use of a spliced mRNA repair template (Aim 1.2). Finally,
I will validate CRISPR-Cas9 screen hits via the intron loss assay to determine which proteins are involved in
various steps of the RT-DSBR pathway (Aim 2.2). Elucidating new roles for RNA and reverse transcription in
DSB repair would expand the fields of genome integrity and could lead to potential new targets for cancer
therapy. Since RT-DSBR would be a more accurate repair pathway in post-mitotic cells that only rely on the
error-prone NHEJ, this research could also elucidate novel DNA repair in cells like neurons.

Public health relevance
PROJECT NARRATIVE Evidence for Polymerase Zeta (PolZ) mediated RNA-templated double-strand break repair (RT-DSBR) in yeast leads us to explore if this repair pathway exists in human cells. I will use novel sequencing and flow cytometry- based assays to test my hypothesis that PolZ is the reverse transcriptase that mediates RT-DSBR in human cells by using endogenous mRNA at the site of the break as a repair template. Comprehensive structure-function analysis of PolZ as a reverse transcriptase, visualization of PolZ recruitment to breaks, identification of endogenous RT-DSBR activity via cis transcribed mRNA, and investigation of factors involved in this pathway will together elucidate an important role for this RT-DSBR in driving error-free repair at highly transcribed genes, and potentially in cancers and nondividing cells.